Cognitive/Personality Factors in Relatives of Alcoholics

Our program of research has been designed around the premise that breaking the cycle of intergenerational alcoholism could be best achieved by intervening in the lives of high-risk children before alcohol abuse becomes entrenched in their life-styles. To accomplish this, we need a better understanding of how to identify those children at highest risk and the predictors of adverse outcome in these special populations. In 1991 we initiated a study of 8-18 year old high (HR) and low- risk (LR) offspring. The high-risk children/adolescents were from families that were multigenerational for alcoholism affectation (ascertained in a previous award [1984-1990]). These multiplex families had been identified through a pair of alcoholic brothers (child's father and uncle who led us to the full pedigree. Analysis of data from that follow-up (7.5 waves) has provided a number of insights for better understanding the risk factors associated with substance dependence in multigenerational families. HR children have a significantly earlier onset to begin drinking, experience significantly elevated rates of child and adolescent psychopathology, and show evidence of neurodevelopmental delay in achieving age-appropriate levels of P300 amplitude and postural control. Neuroimaging has revealed a lateralized reduction in amygdala volume in HR offspring. Lateralized increases in tissue volume occur during adolescence in limbic areas including the amygdala. Our amygdala results may also point to a neurodevelopmental delay in HR offspring. These markers will ultimately be related to outcome. Our Young Adult follow-up already indicates greatly elevated alcohol dependence in the HR group. The proposed work would include: (1) an 8-18 year old replication sample (N=150) of younger siblings and (2) would extend the Young Adult follow-up to include 361 individuals (many were seen in the child/adolescent follow-up). Consequently, a large number of sibling pairs can be studied using familial resemblance techniques. The existence of a new cohort that includes younger children than are currently being followed would enable us to conduct a longitudinal neuroimaging/P300 study in children before significant drinking has begun and relate this to the expected P300 developmental changes. The replication would include measures previously used in the first 8-18 year old follow-up thus allowing confirmation of our neurodevelopmental delay hypothesis. New measures will be added to explore non-shared environmental effects in these families where sibling pairs are available for study (N=346 sib pairs).